Dual-targeted DOTA CAR T cells with image-guided monitoring for solid tumor treatment

Abstract
CAR T cells can mediate deep, durable cancer remissions but their activity is not controllable once infused, they
are not easily tracked, their risk for toxicity remains an issue, and they are seldom designed to combat the
immunosuppressive tumor microenvironment (TME). To provide a means for quantitative control of CAR T cell
activity, our team first created universal immune receptors (UniCARs), a versatile CAR-like platform for the de
novo generation and quantitative control of tumor antigen-specific T cells where human T cells are genetically
engineered with adaptable docking immune receptors and can be conferred with highly personalized tumor
specificity via pre-targeting with “tagged” antigen-specific small molecules, antibodies, scFvs or receptor ligands.
Building upon these principles, and with a multidisciplinary team of physicians and researchers with scientific
expertise in advanced T cell gene-engineering with molecular imaging and chemistry, we propose clinical
development of an orthogonal imaging-enabled, adaptable CAR T cell (ImAC) platform where localization of
infused UniCAR T cells can monitored via noninvasive PET imaging and UniCAR activity can be controlled
through the administration of “tagged” biologics in order to facilitate safe and effective targeted therapy for
cancer. This theranostic ImAC method utilizes a single UniCAR construct with two novel and distinct agents that
share the same clinically-validated CAR-binding tag (DOTA); an imaging small molecule, [18F]-DOTA-Y, that
permits tracking of the cellular product, and a new targeting biologic, folate-DOTA-Y, that redirects the specificity
and activity of UniCAR T cells against folate receptor expressing cells. Folate receptor isoforms are expressed
by the majority of ovarian cancers and by most immunosuppressive tumor-associated macrophages (TAMs) in
the TME, allowing simultaneous targeting of cancer and TAMs via dosing with a single agent. An additional
benefit, beyond the immediate scope of this study, is that targeting biologics can also be applied for diagnostic
imaging prior to CAR T cell delivery to assess localization of the agent to the tumor, to predict response to
therapy, and to test for potential on-target off-tumor toxicity. In the UG3 phase, the goal of our multidisciplinary
team is to refine and optimize the ImAC method to validated optimal dosing schedules, routes and concentrations
that confer a strong tumor response, and to confirm small molecule-based imaging of the administered CAR T
cells in mouse xenograft models of ovarian cancer. With this data in hand, and with the small molecule targeting
biologic being generated by the Immune Cell Network Core (ICN), we will seek to conduct a 3+3 dose-escalation
phase I clinical trial of administration of autologous UniCAR T cells with folate-DOTA-Y for recurrent high grade
serous ovarian cancer with PET-based imaging of the infused cell product in the UH3 phase of the study.
Successful clinical development of this ImAC platform will significantly advance CAR gene therapy by allowing
for the therapeutic coupling of adaptable antigen-targeted T cells with PET-guided monitoring for therapeutic
activity, drug delivery and safety in vivo, which can be readily re-deployed for the treatment of other malignancies.

Public health relevance
Project Narrative: Solid tumors are hard to treat with CAR T cells because the antigens they express are heterogenous. We propose the clinical translation of an approach that synergizes clinical imaging with T cell therapy to overcome the current limitations of toxicity, antigen loss variants and cost of engineered T cell therapy through the application of a bio-orthogonal image-enabled adaptable CAR (ImAC) method where CAR T cells can be tracked by imaging after infusion, and delivery of CAR T cells with tailored payloads can be monitored through noninvasive imaging. We will optimize the ImAC method in rigorous preclinical assays and then test feasibility, safety and response in a Phase I clinical trial for women with advanced ovarian cancer.